Assessing Medical Student Applicants and Matriculants and Medical School Selection Criteria

ABSTRACT
The affirmative action restrictions issued by the Supreme Court of the United States (SCOTUS) on June 29,
2023, significantly limit the use of race-conscious admissions in higher education. The impact of this court
ruling extends beyond undergraduate education to encompass MD and MD-PhD programs, where affirmative
action has played a vital role in raising the representation of Black, LatinX, and Native American students from
less than 2% in 1964 to over 20% in 2022. Prior state-level affirmative action bans have been associated with
a 37% relative reduction in the proportion of matriculated students from underrepresented ethnoracial
backgrounds. As such, restricting affirmative action nationally threatens decades of progress in improving
healthcare workforce diversity. This is alarming, considering the benefits of an ethnoracially diverse physician
and physician-scientist workforce, which include improved access to care, higher quality of care, better
treatment outcomes for both minoritized and white patients, and greater scientific innovation. The
consequences of the SCOTUS affirmative action restrictions are currently unknown, and the ruling poses
several knowledge gaps that we seek to address in this study. Firstly, we will determine the impact of the
SCOTUS affirmative action ruling on MD and MD-PhD program racial and ethnic diversity and the climate of
equity and inclusion within MD and MD-PhD programs. Second, we will describe how MD and MD-PhD
programs adapt applicant selection criteria following SCOTUS restrictions on race-conscious admissions.
Third, we will characterize the application and matriculation experiences of Black, LatinX, and Native American
MD and MD-PhD students following SCOTUS affirmative action restrictions. Our findings will be disseminated
widely as peer-reviewed scientific publications, conference presentations, policy and advocacy reports, and
podcasts to various stakeholders in education and health policy via partnership with the Association of
American Medical Colleges, the American Medical Association, and the National Academy of Medicine.

Public health relevance
PROJECT NARRATIVE The affirmative action restrictions issued by the Supreme Court on June 29, 2023, pose an existential threat to the ethnoracial diversity of the healthcare workforce. This study aims to investigate the impact of this court ruling on the compositional diversity and climate of equity and inclusion within MD and MD-PhD programs. The findings will inform crucial medical education policy decisions.